Mechanisms of cancer immunotherapy-associated thrombosis

Cancer immunotherapy is one of the most important advances in cancer treatment in decades, and has rapidly
moved to front-line therapy for many cancers. The mechanism of cancer immunotherapy is to disable normal
immunoregulatory pathways through administration of Immune Checkpoint Inhibitors (ICI), which are monoclonal
antibodies directed toward key immune regulatory proteins including PD-1, PD-L1 and CTLA-4. Disabling these
pathways enhances anti-tumor immunity. However, since these responses are not tumor-specific, ICIs are
associated with a variety of immune-related adverse events (irAEs). We and others have recently reported a
high incidence of thrombosis, which may exceed 20%, in patients treated with ICI; given the increasing use of
ICIs in cancer treatment and the frequency of cancer diagnoses, it is clear that ICI-Cancer Associated
Thrombosis (ICI-CAT) has become a major clinical problem and that better understanding of this disorder is
urgently needed. However, there is little information available concerning mechanisms of ICI-CAT, and there are
no published studies addressing this issue. We hypothesize that ICI-CAT is an irAE resulting from ICI-induced
cellular activation and prothrombotic activity in the setting of underlying tumor-associated inflammation. Our
murine model demonstrates that ICI-CAT requires the presence of an underlying tumor, with markedly increased
expression of tumor cell tissue factor (TF) occurring after ICI treatment. Our model also supports a role for
neutrophil extracellular traps (NETs) and platelet activation in ICI-CAT; platelet activation is also suggested in
patients treated with ICI by our demonstration of increased levels of circulating platelet-neutrophil aggregates.
On a cellular level, anti-PD-1 antibodies stimulate neutrophil NET release and prothrombotic activity, and may
also enhance platelet activation in the presence of subthreshold thrombin concentrations. In this application, we
propose to advance our understanding of ICI-CAT using both cellular and animal models, and to extend these
studies to clinical samples from patients before and after initiating treatment with ICI. In Aim 1, we will determine
the effect of different ICI and ICI combinations on the development of thrombi in tumor-bearing mice, and assess
our model using other tumor types and mouse strains. We will examine thrombus size and composition, and
identify critical cell types involved in thrombus formation by depleting mice of T cells, neutrophils, monocytes or
platelets. We will also further define the cellular mechanisms involved in expression of prothrombotic activity
using isolated leukocytes from normal human donors, mixed leukocyte populations, and endothelial cells,
incubated with cytokines and ICI. In Aim 2, we will extend these studies by measuring mechanistic markers of
inflammation and vascular activation in patient plasma before and after initiating ICI, and by comparing
procoagulant gene expression in myeloid cells from patients treated with ICI who did, or did not develop
thrombosis. Taken together, these studies should provide important new information leading to better
understanding of mechanisms, and potentially new approaches for prevention and treatment of ICI-CAT.

Public health relevance
PROJECT NARRATIVE Immunotherapy is one of the most important new approaches to cancer therapy to emerge over the last several decades but is associated with unique side effects that often mimic immune diseases. Recent studies have identified thrombosis (excessive blood clotting) as an important side effect of immunotherapy, however, nothing is known about the underlying causes of blood clots in these patients. The goal of this application is to define these mechanisms using patient samples and a mouse model of blood clots induced by immunotherapy.